ICP-QQQ

Project Summary/Abstract: The overall goal of this proposal is to acquire funds to purchase a triple quadrupole mass spectrometer and a new microwave digestor to replace a 14-year old Agilent 7500ce ICP-MS and a MARS5 microwave. The funds will be used to purchase an Agilent 8900 ICP-QQQ system that can be coupled with our existing Agilent 1260 HPLC system which will be dedicated to support NIH-funded investigators requiring quantitative metal analysis, including metal speciation. A group of investigators (6 major, 5 minor) has been identified whose research (75.1% NIH-funded) will greatly benefit from analyses performed with the requested instrumentation. The Trace Metals Lab (TML) in the Department of Environmental Health and Engineering at Johns Hopkins Bloomberg School of Public Health houses the only ICP-MS in the medical campus, which includes the School of Medicine (SOM) and the School of Public Health. The TML has been providing accurate, sensitive, and reliable trace metal analysis for health-related research since 2006. This shared resource provides funded investigators with technical expertise and access to large equipment for quantitative analysis of trace metals. The JHU TML is used heavily by NIH-funded grants supporting research that ranges from exposure to metals from e-cigarettes (R01), evaluation of Magnetic Hyperthermia Therapy (MHT) against infiltrating glioblastoma (R01) and liver cancer tumors (R01), assessment of arsenic exposure on immune responses to influenza (R01), Arsenic and other metal exposures in American Indian communities (R01), among others. The research that will benefit from this instrumentation will have enormous impacts on the disciplines of Medicine and Public Health. With ICP- QQQ, HPLC, microwave digestion, and Single Particle analysis capabilities, our lab will continue to advance the translation of basic biomedical research to treatments and cures, and will also contribute to prevention through strategies for reducing exposure to environmental pollutants for diverse populations. The number of basic and clinical investigators requiring analytical services of trace metals has experienced a rapid growth. As a result, usage of the existing ICP-MS instrument is currently at full capacity. The new instrumentation will also benefit studies that are not currently NIH funded, pilot projects to collect data for NIH grants, and student research projects. The ICP-MS capability of the JHU TML will also contribute to the long-range biomedical research goals of the Johns Hopkins University. This instrumentation will benefit research to understand basic cellular toxicity, risk factors for infection, develop important new therapeutic strategies against cancer, and advance our understanding of stroke mechanisms, heart disease, cancer survival, and immune responses. As outlined in this application, acquisition of this equipment will make this technology available to a large number of investigators, continuing with the goals of the Trace Metals Lab, the Department of Environmental Health and Engineering, the Bloomberg School or Public Health, the Johns Hopkins University, and the Biomedical community as a whole.

Public health relevance
Project Narrative: The ability to quantify metals in cells, plasma, tissues and environmental media with high sensitivity and selectivity is an essential need of research projects that aim to assess exposure to environmental pollutants, to improve the treatment of diseases, and to understand the basic mechanisms of toxicity. The proposed updated analytical instrument will bring very reliable and robust instrumentation necessary to the Johns Hopkins Medical campus, thereby advancing many projects that seek to improve Public Health as well as treatment of serious diseases such as cancer.